Threat-Related Negative Valence Systems, Child Victimization, and Anxiety_Supplement

Interpersonal violence (IPV) exposure affects 1 in 2 youth and levies tremendous physical and mental health
burdens on victims and society. Childhood IPV exposure is a well-established risk factor for anxiety and other
mental health problems across the lifespan. A paucity of longitudinal studies assessing multiple threat-related
mechanisms, across multiple units of analysis, and at key times in development has been a critical barrier to
informing the design of personalized treatments to target root causes of post-IPV psychopathology. The
overarching goal of this project (the “CHARM study”) is to examine developmental trajectories of threat-related
NVS measures into adolescence, as a function of exposure to IPV, in an effort to better link IPV and anxiety
through changes in these measures. The specific aims of this project are: 1) to identify threat-related NVS
constructs that connect lifetime IPV to anxious symptoms in youth cross-sectionally; 2) to investigate
longitudinally the degree to which IPV sensitizes trajectories of NVS measures across three age cohorts (grades
3, 6, 9 at baseline); and 3) to investigate the degree to which trajectories of NVS measures predict anxiety
symptoms over time after accounting for initial anxiety symptoms and IPV status. The study had successfully
recruited its full sample (N=364) and longitudinal retention was progressing as planned until March, 2020, when
the COVID-19 pandemic (and subsequent mandatory guidelines impacting in-person data collection) reduced
retention across the representative sample. Pandemic disruptions have required increased intensive efforts in
participant retention, particularly for the final assessment (Lab Visit 3) that includes the follow-up fMRI scan,
which has translated into a delayed timeline and increased costs. The proposed Administrative Supplement is
essential to help cover these unexpected costs to complete the outstanding in-person data collection, as well as
final data cleaning, analysis, and write up of results, ensuring that the longitudinal aims are successfully met and
that maximum impact is yielded from the study.

Public health relevance
The central goal of the funded R01 parent project is to improve understanding of how childhood violence exposure impacts mental health by studying the links between patterns of violence exposure, aspects of biological and psychological functioning, and different types of emotional distress across key developmental transitions from childhood into adolescence. By identifying mechanisms that connect violence exposure to mental health problems, results of this study will inform improvements to current strategies for assessment, diagnosis, classification, treatment, and prevention of emotional distress among violence-exposed youth. The supplemental funds requested will allow for the collection of critical follow-up data collection, which had been disrupted by the Covid-19 pandemic but are vital for completing the study’s longitudinal aims.